Evaluating Pathways Involved in Melanoma Initiation

ABSTRACT
Melanoma is a devastating type of cancer, and despite recent advances in targeted or immunologic therapies,
many patients relapse. We study melanoma using a zebrafish model with melanocyte-specific expression of
human BRAFV600E or other oncogenes in the background of a variety of tumor suppressor mutations. With
zebrafish genetic and chemical biology tools, we hope to reveal critical pathways that participate in the initiation
and formation of melanoma. We have observed the onset of melanoma using a neural crest specific transgenic
reporter for crestin, a neural crest progenitor gene that is expressed early in neural crest development and shuts
off by day 5 of zebrafish development. When a melanoma arises, crestin expression reactivates in single cells
transforming into melanoma. We recently found that the initiating cell is derived from a zone of hundreds of cells
that express higher levels of the master melanocyte regulator MITF and display aberrant morphology. We called
this region a cancer precursor zone (CPZ) and found analogous regions that express MITF and another
conserved gene, ID1, in early human melanocyte lesions and melanoma in situ. Using novel cellular barcoding
technologies such as CRISPR-based GESTALT, we have shown the CPZ is oligoclonal from which a single
malignant clone expands to form melanoma. We also showed that BMP, which induces ID1 clonally expands
CPZs. Using the color-based Palmbow, we will study gene expression in clones of CPZ and early tumors and
use imaging to study the clones. Clonal mapping using mitochondrial sequencing of human melanomas will
confirm our observations in zebrafish. We plan to use proteomics and zebrafish genetics to examine the
pathways involved in neural crest reactivation from the CPZ. Using proteomics, we have found growth factors
and receptors that are expressed in crestin+ patches and not CPZs, such as midkine b that is known to regulate
neural crest development. Overexpression and knockout experiments will be used to test the sufficiency and
requirement of these proteins for causing tumor initiation. The CPZ is also associated with increased oxidative
stress, and we found the antioxidant gene ApoD is expressed at higher levels in early crestin+ patches and
drives the transition to overt tumors. One function of ApoD is to convey resistance to ferroptotic death and to
enable tumor initiating cells to handle more reactive oxygen species (ROS). Overexpression of ApoD leads to
an increase in both tumor incidence and abundance in zebrafish. We plan to use genetics and cell biology,
including leveraging MAZERATI, a tissue-specific CRISPR technology, to understand the mechanism by which
ApoD controls ferroptosis and how the protection from ROS and ferroptosis plays a role in melanoma initiation.
We also plan to use our color based and CRISPR cellular barcoding technologies to investigate if ROS resistance
and suppression of ferroptosis by ApoD leads to clonal selection and tumor initiation. Our studies will improve
the understanding of cancer initiation and progression. This may lead to the identification of new biomarkers or
drug targets, yielding early diagnosis and new preventative therapies for melanoma.

Public health relevance
PROJECT DESCRIPTION Cancer initiates from zones of cells that are preprogrammed to transition to malignant cell states. We plan to examine signaling pathways that activate cancer from these cancer precursor zones (CPZ) and have identified ApoD as a gene that causes the transition from a CPZ to a tumor by conferring resistance to oxidative stress. We plan to examine initiating clones of melanoma. Our studies will have an impact on understanding how cancer starts and may allow for the development of more accurate diagnoses and treatments that could prevent cancer.